In silico identification of population-specific disease pathways

PROJECT SUMMARY/ABSTRACT Alzheimer's disease (AD) has a complex mode of inheritance, and the combined effect of the now well replicated late-onset AD genetic risk loci are estimated to account for less than 40% of its genetic risk. There is no cure yet for this devastating neurodegenerative disease that affects approximately 5 million Americans, and the current treatments are only capable of ameliorating the symptoms. Therefore, it is imperative to gain a better understanding of each of the genetics factors that are linked to the development of the disease, especially in underrepresented minorities such as African-Americans, with the goal of unifying this information into better informed designs for therapies and possibly preventive interventions. Importantly, most genetic studies of AD have been conducted utilizing subjects primarily of European descent, yet AD is twice as prevalent in African-Americans. Meanwhile, studies addressing AD in African-Americans have revealed different AD risk variants from those identified in subjects of European descent. Given these disparities, the goals of the proposed study are to (1) identify specific biological pathways, and their genes and genetic variants that may impact the development of AD differentially in African-Americans versus subjects of European descent, by implementing a gene-set enrichment paradigm using pre-existing genome-wide association study (GWAS) datasets specific to these two populations, and (2) to determine if additional pathways, and their genes and genetic variants can be discovered by using results from existing whole exome sequence datasets. This project has the goal of integrating information that could lead to better informed designs for therapies and possibly preventive interventions, which could potentially be tailored to AD in African- Americans.

Public health relevance
PROJECT NARRATIVE Our group and others have demonstrated that genetic factors that associate with increased risk of developing Alzheimer's disease (AD) in African-Americans sometimes differ from those identified in subjects of European descent. Given this disparity and the fact that AD is twice as prevalent in African-Americans as in subjects of European descent, and that African-Americans are an underrepresented population in studies of Alzheimer's disease, we propose to identify genetic risk factors that differentially influence AD risk in African-Americans vs. subjects of European descent, by implementing a gene-set enrichment paradigm using pre-existing genomic datasets specific to these two populations. The proposed study will identify biological pathways, genes and genetic variants that affect the risk of AD differentially between African-Americans and subjects of European descent, and which will serve as therapeutic targets for improved, population-specific, AD treatments.